Fast Dissolving MM008 Tablet for Instant On-Demand Non-Hormonal Contraception

Project Summary
Nearly half of all pregnancies in the U.S. are unintended, and most occur in women who are not using
contraceptives. There are diverse reasons for not using contraceptives; one common reason is that many
women have strong aversion to using exogenous hormones, due to real and/or perceived side effects.
Furthermore, women’s contraceptive preferences are diverse: while some strongly prefer the convenience and
sustained contraceptive activity of an intravaginal ring (IVR), others strongly prefer discrete methods that can
be used on-demand during infrequent intercourse. Thus, a suitable delivery format is equally important as the
underlying contraceptive mechanism. Current on-demand contraceptive options, such as gels/films/condoms,
each faces substantial limitations, including limited effectiveness, substantial toxicity, and/or inconvenient
dosing timing and format. A non-hormonal contraceptive that is fast-acting with prolonged (i.e. many hours of)
activity, safe, effective, not messy and discreet would meet the needs of many women seeking on-demand
contraception, but are not met by any of the currently available contraceptive products. We are creating such
a non-hormonal contraceptive (product code: MM008) by formulating Mucommune’s proprietary highly
multivalent anti-sperm monoclonal antibodies (mAb) into fast dissolving antibody tablets (FDATs). We
previously developed a mAb termed FFIFF that binds a well-characterized and validated antigen target present
only on human sperm and cells from the male reproductive tract, but are otherwise absent in all tissues in
women. Due to its highly multivalent nature, FFIFF potently agglutinate and trap sperm in CVM (>16-fold
greater than parent HC4 mAb in standard IgG format), thus effectively preventing individual progressively
motile sperm from reaching the egg. More recently, we engineered an improved molecule termed LamH10,
which possess even greater avidity and potency against sperm at physiological temperature (37˚C), exceeding
the activity of the parent HC4 IgG by over 100-fold. We have also successfully formulated LamH10-FDATs,
comprised of a proprietary blend of safe and routinely used excipients, with rapid disintegration (<2 min) and
high contraceptive efficacy in human cervicovaginal mucus (CVM) that, in pilot sheep studies, reduced
progressively motile sperm by >99.9% in the sheep vagina within <5 mins of tablet insertion. LamH10 is the
lead MM008 molecule. Building off of these promising results, we seek to quickly advance MM008-FDAT
through IND-enabling preclinical studies. We will develop cGMP production processes that necessary support
the manufacturing of FDATs for IND-enabling and Phase 1-2 studies (Aim 1A), and file and receive feedback
from the FDA on a Type B pre-IND submission (Aim 1B). We will produce tox materials and complete GLP
vaginal tox studies and rabbit vaginal irritation studies following FDA guidance (Aim 2). Successful completion
of these aims will put us in a position to file IND for MM008-FDAT pending manufacturing of clinical trial
materials, and solidify the foundation for future contraceptive products being developed at Mucommune.

Public health relevance
Narrative Statement In the U.S., nearly half of all pregnancies are unintended, incurring a cost burden of over $20B to the federal and state governments each year. We have formulated a potent anti-sperm antibody into fast dissolving antibody tablets, and here, we will develop tablet manufacturing processes and execute key preclinical studies. Successful completion of this project will enable us to quickly advance a safe, effective non-hormonal on- demand contraceptive into clinical evaluation.